PET/CT Imaging of Venous Thromboembolism in Pediatric, Adolescent, and Young Adult Oncology

PROJECT SUMMARY
The long-term goal of this work is to develop a non-invasive imaging strategy for quantifying chemotherapy-
induced vascular toxicity to better understand the potential role of image-derived measures of venous
inflammation for predicting risk for venous thromboembolism (VTE) in pediatric, adolescent, and young adult
(AYA) patients undergoing cancer treatment. Chemotherapy is known to have off-target vascular effects that
increase the risk for VTE. In spite of this recognized risk, risk models are not regularly used to guide
preventative anticoagulation in young cancer patients and preventative thromboprophylaxis is traditionally
avoided due to a high risk of bleeding associated with cancer and concurrent chemotherapy. Therefore, there
is a need for biomarkers that can assess chemotherapy-induced toxicity, identify patients at highest risk for
VTE, and detect the potential anti-inflammatory vascular effects of thromboprophylaxis. In this proposal, we will
validate and test a molecular imaging approach for characterizing chemotherapy-induced venous toxicity from
PET/CT images acquired as part of routine care in pediatric and AYA patients undergoing treatment for
lymphoma. To accomplish this overarching goal, we will first pre-clinically validate 18F-FDG PET/CT imaging as
a non-invasive biomarker of chemotherapy-induced venous toxicity. We will then clinically evaluate the
prognostic value of our imaging approach for predicting risk for VTE by collecting whole-body PET/CT images
from a large multi-site cohort of pediatric and AYA patients with lymphoma and prospectively monitoring
occurrence of VTE events. Following pre-clinical validation and clinical testing of our approach, we will assess
the utility of 18F-FDG PET/CT imaging for detecting the anti-inflammatory actions of standard
thromboprophylaxis methods. Validation of PET/CT imaging for detecting venous toxicity, risk for VTE, and
responses to thromboprophylaxis could provide a non-invasive approach for enabling real-time monitoring of
adverse vascular effects associated with cancer treatment in pediatric and AYA patients and identifying those
at high risk for VTE.

Public health relevance
PROJECT NARRATIVE Venous thromboembolism (VTE) is an increasingly prevalent problem for pediatric, adolescent, and young adult (AYA) cancer patients, which can be partially attributed to off-target effects of chemotherapy treatments that damage the vascular endothelium and create a pro-inflammatory environment. PET/CT imaging with the radionuclide 18F-FDG is standard of care for monitoring treatment responses in many cancers, but could provide additional insight into chemotherapy-induced venous toxicity and risk for VTE events by allowing for quantitative assessment of serial changes in venous inflammation. In this project, we will validate 18F-FDG PET/CT imaging as a non-invasive approach for evaluating chemotherapy-induced venous toxicity and risk for VTE events, thereby laying the foundation for the use of image-derived measures of venous inflammation to enhance personalized plans for thromboprophylaxis and promote improved quality of life for pediatric and AYA cancer patients.